Mentoring Biomechanics Research in Osteoarthritis

PROJECT SUMMARY/ ABSTRACT
This is a renewal for a Midcareer Investigator Award in Patient-Oriented Research (K24). The applicant, Dr.
Richard Souza, is a clinician-scientist, Professor in Physical Therapy and Rehabilitation Science at the University
of California, San Francisco. Throughout his career, Dr. Souza has built upon his clinical background through
detailed and comprehensive studies on the influence of loading mechanics on knee and hip osteoarthritis (OA).
These studies have used biomechanical methods such as motion capture systems, accelerometer-based activity
monitoring, and strength assessment through dynamometry, and have characterized disease status and
progression using advanced quantitative MRI metrics including T1ρ and T2 relaxation time mapping of knee and
hip cartilage. Combining his background in musculoskeletal biomechanics with the world-renowned research
team in the Department of Radiology and Biomedical Imaging at UCSF, Dr. Souza has been able to uncover key
biomechanical variables that contribute to the earliest changes in the OA process. These efforts have resulted
in a series of R01 awards on joint mechanics in OA, including a recently funded MPI R01 on bone and cartilage
interaction in persons with patellofemoral joint OA (R01 AR079647). Understanding the predictive capability of
lower extremity joint biomechanics to identify disease progression has been the driving force of Dr. Souza’s
work. The team of investigators at UCSF in the Musculoskeletal Quantitative Imaging Research group, including
Drs. Sharmila Majumdar, Thomas Link, Daehyun Yoon, Galateia Kazakia, and numerous other have built a
collaborative infrastructure ripe for mentoring trainees with interest in the intersection of biomechanics and
quantitative imaging. The current application requests funding (50% salary support) for 5 years to support the
protected time necessary to conduct the proposed patient-oriented research and to expand opportunities for
mentoring within the UCSF community. This protected time will allow Dr. Souza to continue to lead a productive
research group and maintain minimal teaching and administrative responsibility at the Departmental and
University levels. Dr. Souza will also obtain additional training in [18]FDG PET MR analysis and tracer kinetics,
pain imaging, both peripherally and centrally, as well as participate in the Training in Clinical Research (TICR)
program. There are plentiful opportunities to expand the work Dr. Souza has begun, and extremely high potential
for clinical break-through in this important area of clinical research.

Public health relevance
PROJECT NARRATIVE Multidisciplinary teams investigating a multifactorial disease process like osteoarthritis is a logical and necessary approach for innovative break-throughs in clinical practice. This award will allow the PI to expand his mentoring of young researchers, junior faculty, postdocs, and PhD students in lower extremity biomechanics and leverage the rich clinical environment at UCSF to open new inroads in clinical research.